Educational Activities

In addition to serving as Editor for Reproductive, Perinatal and Pediatric papers submitted to the American Journal of Epidemiology and the Summer Institute (covered in a separate Annual Report entry), Dr. Klebanoff gave the following educational lectures in FY 2009 Invited lecture, CDC Workshop on Surveillance for Stillbirth, October 2008 "Estimating Gestational Age: Overview and Challenges" Design and Conduct of Randomized Clinical Trials - Educational Workshop at the Society for Maternal- Fetal Medicine February 2009;and the Society for Pediatric Research, May 2009. Analysis of Publicly-Available Data, Educational Workshop at the Society for Maternal-Fetal Medicine, February 2009. Invited presentation, Student Caucus, Society for Epidemiologic Research, June 2009 "Research Career: Epidemiology at NIH" Invited presentation, Johns Hopkins Summer Epidemiology Institute, July 2009 "What Journal Editors Look for in a Manuscript"